Establishing patient-derived iPSCs as a platform for discovery research in NAFLD

PROJECT SUMMARY/ABSTRACT
Our research group studies human NAFLD using patient-derived induced pluripotent stem cells (iPSCs) for in
vitro disease modeling. We recently showed that iPSCs from a cohort of NAFLD patients, when differentiated
to hepatocytes (iPSC-Heps), display a spontaneous disease signature in cell culture. This underscores the
importance of genetic background to NAFLD disease modeling and offers a unique opportunity to study the
impact of NAFLD risk genes on disease phenotype. We theorize that the disease phenotype in NAFLD iPSC-
Heps is due in part to established genetic risk factors identified through GWAS and in part to others that are
either poorly characterized or unknown. To address the impact of established and emerging genetic risk
factors on the NAFLD phenotype in iPSC-derived liver cells, we will leverage our unparalleled collection of 61
disease-specific iPSC lines (41 NAFLD, 19 control) and our ability to differentiate iPSCs along multiple liver cell
lineages to create mono- and co-cultures. In the course of three aims we will systematically study these cells
and catalogue the resulting resources and information for dissemination to the hepatology community. In Aim 1
we will develop a scorecard comprising the results of 15 transcriptomic, proteomic and functional assays for all
61 iPSC lines. The data will be used to develop individual and aggregate measures distinguishing normal from
diseased cellular phenotypes and correlate phenotypic profiles with individual and polygenic risk factors. This
aim will generate a large body of multi-omic data in the NAFLD iPSC model system that will be used as the
foundation for subsequent gene editing. Aim 2 will constitute a systematic effort to correct 113 variant genes in
33 NAFLD iPSC lines and repeat the full scorecard analysis after each edit. Comparisons will be made
between scorecards from individual gene-edited vs. parent lines, as well as in groups of iPSCs with similar
edits. Many iPSC lines will be subjected to sequential gene corrections and may revert to normal; iPSC lines
whose scorecard does not normalize will be scrutinized for the presence of novel variants with a plausible
disease association, followed by direct testing with further gene correction. Aim 3 will employ a complementary
but independent strategy involving whole-genome CRISPR screening in a NAFLD iPSC line to identify genes
whose inhibition suppresses a NAFLD signature. This aim will make use of fluorescent reporter iPSC lines and
high-content imaging to assess NAFLD-related outcomes. The CRISPR screen will enable us to discover novel
genes that have a direct impact on cellular phenotype and may be suitable for translation to the clinic. This
RC2 project will yield several deliverables: (a) rich, multi-omic datasets from a large cohort of parent iPSC lines
and isogenic gene-edited derivatives following multicellular differentiation and NAFLD modeling; (b) > 100
iPSC lines from which the data were generated; and (c) an iPSC line from a NAFLD subject transduced with an
arrayed whole-genome CRISPRi library suitable for future screening studies. Each of these resources will be
made freely available on open web-based platforms or biorepositories.

Public health relevance
PROJECT NARRATIVE Nonalcoholic fatty liver disease (NAFLD) is a common and potentially very serious disorder that can lead to cirrhosis and liver cancer. A person’s genetic background represents an important risk factor for NAFLD and the risk involves the combined effect of many genes. The goal of this research project is to use stem cells previously generated from NAFLD patients to understand how multiple genetic risk factors combine to cause NAFLD. This information will help us tailor NAFLD treatments to individual patients based on their genetic profile.